Cancer Data Science (CDS)

PROJECT SUMMARY/ABSTRACT (CANCER DATA SCIENCE SHARED RESOURCE)
The mission of the Cancer Data Science Shared Resource (CSD-SR) is to enhance the scientific excellence of
research at Rogel Cancer Center (Rogel) by providing biostatistical, bioinformatics and clinical informatics
support across the spectrum of basic, translational, clinical and population sciences research. CDS-SR consists
of highly trained quantitative scientists (faculty and staff analysts) who assist Rogel investigators to execute data
analyses and conceptualize and develop research projects and clinical trials. CDS-SR personnel collaborate
with Rogel members for dissemination of analytical findings in the form of inferences and hypotheses for
validation and interpretations for publication. During the project period, SR personnel collaborated, consulted, or
interacted with 229 different Rogel investigators from all six Research Programs on cancer research projects,
co-authored 479 cancer-related publications, were supported by 91 cancer-related grants and participated in
128 clinical protocols.